Genetic contribution to loss of B cell anergy during development of type 1 diabetes

Project Summary/Abstract
This proposal for a five-year mentored research career development project focuses on elucidating
the role of the type 1 diabetes (T1D) PTPN2 risk allele in loss of B cell anergy. Previously B cells
bearing antigen receptors with high affinity for insulin were found only in the anergic B cell compartment of
healthy individuals. Importantly, these cells leave this compartment in a proportion of first-degree relatives
(FDRs), and in all autoantibody positive pre-diabetics and recent onset diabetics. Departure of these
autoreactive anergic B cells in FDRs was shown to be associated with high risk T1D HLA alleles, and three
high risk non-HLA alleles, including INS (rs689), PTPN2 (rs1893217), and IKZF3 (rs2872507). Of the three
non-HLA risk alleles, only PTPN2 has been previously shown to be a negative regulator of signaling. However
these previous studies were completed in mice, not humans, and their exact mechanism by which they
contribute to development and signaling has yet to be determined. This application proposes to determine the
effect of the T1D risk variant of PTPN2 in maintenance of B cell anergy. Aim 1 will explore the effect of the risk
variant on the phenotype of the B cell compartment in FDRs of T1D patients and their response to stimulation.
Aim 2 will explore the relationship of loss of anergic B cells with the high risk T1D genotype allele, Ptpn2, using
a reductionist mouse model. The potential impact of these studies will lie in understanding how risk alleles
conspire to undermine maintenance of immune tolerance to autoantigens in T1D.
The candidate is an Instructor at the Barbara Davis Center for Diabetes and has brought together a
diverse team of experts to serve on her advisory committee. The outlined proposal builds upon the candidate's
previous research but will enable advancement of technical and analytical skills utilizing state-of-the-art
technologies and will allow pursuit of new avenues of B cell research. In addition, the training and development
plan is comprehensive and tailored to her needs, which will enable her to transition to independence as a
highly productive veterinary scientist in the field of autoimmunity.

Public health relevance
Project Narrative In this application I propose a career development plan to transition me to an independent scientist. I propose to define the mechanisms by which the type 1 diabetes PTPN2 risk-allele contributes to loss of anergy in B cells during the pathogenesis of disease. The overarching goal of these studies is to better understand how genetic factors contribute to type 1 diabetes by altering the status of autoreactive anergic B cells in hopes of translating findings into novel therapeutic targets to treat the disease.